"Off-the-Shelf" iPSC-Derived Regulatory T Cell Immunotherapeutics

Abstract We propose to develop nontoxic, tunable off-the-shelf chimeric antigen receptor (CAR) cell-based
immunotherapy to treat acute myeloid leukemia (AML). Murine CD19 CAR CD4 Treg adoptive transfer fully
prevented graft-versus-host disease (GVHD) and eliminated all CD19 lymphoma cells. Surprisingly, the
mechanism was not CD4 Treg mediated suppression of Teffectors to below that needed for GVHD but above
that needed for graft-vs-leukemia (GVL). Instead, these Tregs had dual suppressor and cytolytic functions as
evidenced by equal killing comparable to Teffectors at a Treg purity level of 99.9%. In vitro and in vivo killing was
ligand dependent. These encouraging data led to testing of human CD19 CAR CD4 Tregs that also killed in a
ligand specific manner. Peripheral blood CAR CD8 induced Tregs (iTregs) were equally potent for target cell
killing as CAR CD8 Teffectors. Human CD19 CAR CD4 Treg adoptive transfer alone rescued 50% of mice from
a lethal lymphoma dose. With encouraging results, we pursued human pluripotent stem cells (iPSCs) that
produce CD8 but not CD4 T cells and are highly amenable to multiplex gene editing due to their self-renewing
properties. These data lead to Our central hypothesis that gene-edited off-the-shelf CD83 CAR iPSC CD8 iTregs
will avoid rejection and exhaustion but retain dual GVHD/GVL function. Edits are designed for site specific
integration or disruption, including Foxp3 (completed), circumventing rejection by macrophages (CD47 over-
expression) and the adaptive immune system by deleting HLA class Ia/II, and STAT3 to render Tregs resistant
to Teffector conversion. Embedded in genome editing are key biological questions as to how changes in proteins
affect the initiation, maturation and function of CD8 iTtregs, providing a great opportunity to study human T cell
development and control mechanisms. CAR therapy for AML is challenging due to on-target/off-tumor toxicity.
We nominated CD83 as differentially expressed on malignant compared to nonmalignant myeloid cells. A
nanobody CAR generated from a camelid library has exquisite potency against AML cells. The requirements for
in vivo persistence and function of CAR CD8 iTregs that correlate with efficacy will be addressed here. While
persisting CAR T cells may control AML, T cells that undergo tonic or repetitive signaling can become exhausted
and unable to control disease. CAR T cells must be tuned for a productive immune response but not overly
vigorous to drive cells into a state of dysfunction manifested by poor effector function, inhibitory receptor
expression and altered transcriptomics and epigenetics. Strategies ranging from TCRα deletion and reliance on
CAR signaling to immunotyrosine activation motif deletion to dampen CAR signaling but leave TCR signaling
intact and to switch CARs turned on/off by stopping a drug dimerizer. Aim 1 hypothesizes that genome modified
off-the-shelf human iPSCs will generate CD83 CAR CD8 iTregs that resist rejection, augment GVL and control
GVHD; Aim 2 hypothesizes that gene-edited human iPSC CD83 CAR CD8 iTregs need intermittent TCR or CAR
signal persistence without exhaustion to effectively suppress GVHD and kill patient AML blasts

Public health relevance
Public Health Relevance Our goal is to develop new therapies for treating patients with relapse/refractory acute myelogenous leukemia (AML). This application proposes to tackle allogeneic hematopoietic cell (alloHCT) complications by using chimeric antigen receptor (CAR) Tlineage cells in a novel approach with unexpectedly potent cell type, induced regulatory T cells (iTregs) that has the dual capacity of preventing alloHCT side-effects and killing AML cells. Using drug regulated system to induce CAR expression for periods of time to restrain AML followed by rest periods to prevent T cells from being exhausted and dysfunction. This is accomplished by administration of a nontoxic drug to turn CAR expression on and stop drug to turn the system off in order to best treat AML, reducing toxicity and improving efficacy.